Investigate The Impact of Third-Hand Smoke on Platelet Function and Thrombogenesis

Even though smoking has been on the decline, there has not been a commensurate decrease in the mortality
and adverse effects associated with it, especially in vulnerable populations such as children and minorities (e.g.,
Hispanic Americans). While the involvement of the well-known first-hand smoke (FHS) and second-hand smoke
(SHS) in the pathogenesis of thrombotic diseases is well documented, the contribution of the newly “discovered”
third-hand smoke (THS) form to such disease processes remains unknown. This derives, in part, from: (1) initial
lack of knowedlge of THS existence; (2) lack of appreciation for its “real” negative health consequences; (3) lack
of a THS-exosure animal model that mimics real-life scenarios; and (4) lack of studies regarding such
consequences on platelet biology. The present application proposes experiments that address fundamental,
mechanistic, epigenetic and clinically-relevant translational aspects of the adverse-health effects of the newly
“realized” form of smoking, THS, in the context of thrombotic disease and platelet biology, and in a gender-
specific manner. Studies are also proposed to investigate, in a similar fashion, the toxicants that underlie THS
effects on platelets and associated diseases. These studies are of paramount significance given the skepticism
regarding THS existence and/or the fact that its dangers are/remain underestimated/unappreciated, despite
evidence that it is more toxic than SHS. The Aims of our proposal are:
Aim 1. Investigate the impact of THS-exposure on platelet-dependent disease states. While compelling
recent evidence revealed that exposure to THS does exert negative health effects, its impact on platelet-
dependent diseases and the contribution of gender to these effects are still unknown. To address this issue, we
will determine the ramifications of THS exposure on normal hemostasis and platelet counts, in a dose-, time-,
and gender-dependent fashion. Subsequent studies will examine whether THS participates in the development
of thrombotic disease, as well as investigate the role of the coagulation system in mediating its toxicity. Our
preliminary data shows, for the first time, that THS modulates physiological hemostasis, suggesting that it may
increase the risk of cardiovascular disease.
Aim 2. Investigate the mechanism by which THS-exposure modulates platelet function. While our
preliminary studies revealed that THS modulates hemostasis, the mechanism, by which it modules platelet
function remains to be investigated. Thus, the overall goal of the experiments proposed in this section is to
determine the significance of THS-exposure on the various platelet functional responses, cytokines, platelet
epigenetics, thrombosis “markers” and other blood cells. Studies are also proposed to investigate whether THS
effects are receptor mediated. It is noteworthy that our preliminary data shows that THS does enhance platelet
function (e.g., aggregation).
Aim 3. Define THS toxins with potent impact on platelet-dependent disease and function. While some
progress has been made regarding specific FHS and SHS toxicants/ingredients that impact platelet activation,
virtually nothing is known in the context of THS. To this end, recent studies, including those by the California
THS Consortium (for which Dr. Martins-Green was a founding member), have shown that nicotine, cotinine, 3-
ethynylpyridine, benzo(a)pyrene, NNAL, as well as acrolein, are amongst the major THS toxicants. Thus, the
impact of these toxicants, alone or in combination, on platelet function and related disease will be investigated,
as per the approaches described in Aims 1 and 2; in order to identify the most potent toxicants. To this end, our
preliminary data revealed that cotinine- one of the major components of THS- does indeed enhance platelet
function.
Collectively, these experiments will make significant contributions to our understanding of the
consequences of THS exposure (an unappreciated health threat) on platelet activation and
cardiovascular human health, as well as the mechanism (e.g., epigenetics) and toxicants by/through
which it exerts these effects, in a gender-specific manner.

Public health relevance
Collectively, the experiments presented in this application, some of which are translational in nature, address fundamental, epigenetic and mechanistic concerns regarding the cardiovascular health effects of the newly realized form of tobacco, i.e., Third-Hand Smoke and the toxicants underlying these effects, by employing a systematic platelet function and related animal model and disease analysis approach. Results obtained from these studies should promote further smoking cessation, as well as lay down the foundation for understanding, and advancing policy and means for evidence-based therapeutic management, prevention and control efforts of tobacco-associated thrombosis-based disease states.